Determining the neuroplasticity role of inhibitory NDNF neurons in motor execution and learning

ABSTRACT
Neuroplasticity is a key feature of cortical systems allowing for flexible shaping of pyramidal cell activity
necessary for learning, adaptation, and recovery from injury. A shared feature of neuroplasticity across cortical
and subcortical regions is the involvement of inhibitory interneurons in refining pyramidal cell activity. In the
motor cortex, pyramidal cells tile their activity to skilled behaviors, likely being shaped by local inhibitory
interneurons. However, how pyramidal cell sequencing emerges in the motor cortex to produce and adapt
skilled behaviors remains unknown. Delineating the mechanisms and circuitry involved in shaping pyramidal
cell sequencing is crucial to understanding the fundamental rules of motor plasticity, and to inform future
therapeutic interventions to enhance neuroplasticity. While previous studies have investigated the role of
interneuron subtypes in motor plasticity; the predominant interneuron in layer 1 of cortex, neuron-derived
neurotrophic factor (NDNF) neurons, has yet to be researched. NDNF neurons have been characterized
across cortical regions including auditory, visual, somatosensory, and prefrontal cortex. While their functional
role across these cortical regions continues to be explored, there is evidence these neurons regulate pyramidal
cell inputs, attenuating top-down inputs and gain-controlling bottom-up inputs. Skilled behavior learning and
execution involves the dynamic combination of top-down inputs originating from the basal ganglia and
bottom-up inputs deriving from the cerebellum to shape pyramidal cell activity. Our overall hypothesis in this
proposal is that motor learning and execution rely on NDNF neurons to refine pyramidal cell activity through
regulation of top-down and bottom-up inputs. To test this, I will first determine the anatomical localization of
NDNF neuron somata, dendrites, and axons. Then, I will establish the dynamics of NDNF neurons in M1
during motor execution and learning using two-photon calcium imaging. Lastly, I will casually test the role of
NDNF neurons on shaping pyramidal cell activity by optogenetically activating and suppressing NDNF neurons
while performing large-scale neural recording of pyramidal cells. In all, this work will establish the role of motor
cortex NDNF neurons in neuroplasticity.

Public health relevance
PROJECT NARRATIVE Regulation of pyramidal cell inputs is crucial for generating skilled movement behavior. Neuron-derived neurotrophic factor (NDNF) expressing neurons are an inhibitory interneuron subtype that have recently been identified as a regulator of layer 1 pyramidal cell inputs. Yet, NDNF neurons' role in regulating pyramidal cell activity that is necessary to drive skilled movement execution and learning has not been explored.